CTSA UM1 Program at Wake Forest

PROJECT SUMMARY/ABSTRACT
The emergence of large integrated health systems linked by common informatics platforms offers an
unprecedented opportunity to study the impact of new therapies, healthcare delivery models, and strategies to
mitigate health disparities in real world settings. Such integrated systems also offer opportunities to test
approaches to implement and scale evidence-based practices, to address gaps in translational science, and to
become Learning Health Systems (LHS). The Wake Forest (WF) Clinical and Translational Science Institute
(CTSI) has pioneered the integration of the academic mission into the LHS framework including T0-T4
translation, scholarship, and education while also addressing the social determinants of health and promoting
the vitality of the communities served. WF leads as the academic core of Advocate Health – the nation’s fifth
largest not-for-profit health system serving nearly 6 million patients across the Southeast and Midwest United
Sates. The aLHS is Advocate Health’s guiding vision, and the WF CTSI is its central resource for supporting
translational science across the entire system. The size of the health system offers a unique opportunity to
develop, demonstrate, and disseminate novel care models in a wide range of settings. With this funding, the
WF CTSI will drive the realization of the full potential of an aLHS and create a model for advancing translational
science in a large academic health system. The need for such a model is urgent, given the ongoing consolidation
of academic and non-academic health systems in the United States and the challenges in conducting research
in busy practice settings. All activities and initiatives to advance translational science will be grounded in a culture
of accountability for enhancing diversity, equity, and inclusion. WF CTSI’s vision will be achieved through the
four specific aims: 1) Support an inclusive and highly effective governance structure that promotes a culture of
continuous quality improvement, enables timely response to regional and national health emergencies, supports
proactive dissemination and implementation, and enables active participation in CTSA-sponsored trials; 2)
Recruit and train a highly competent and diverse aLHS workforce and engage the full range of patient and
community stakeholders who are essential to improving health and mitigating health disparities; 3) Provide
resources to promote innovative pragmatic study designs, support pilot studies that address key translational
roadblocks, and satisfy the needs of the aLHS research community for timely access to data from electronic
health records, population surveys, omics analyses, and other sources; and 4) Enhance translational efficiency
through projects testing novel methods (e.g., respondent driven sampling to improve patient recruitment,
integrating patient generated data into the EHR). Innovations made in achieving these aims will be shared
through and beyond the CTSA national network.

Public health relevance
PROJECT NARRATIVE The Wake Forest Clinical and Translational Science Institute (CTSI) seeks to create a model for advancing translational science in a large academic health system with activities grounded in a culture of accountability for enhancing diversity, equity, and inclusion. Development of such a model would have great impact on human health given the rapid consolidation of academic and non-academic health systems in the United States and the challenges in conducting research in busy practice settings. Overcoming roadblocks and challenges associated with translational science in environments of the size and scope of large medical centers will greatly accelerate the development of effective techniques for the prevention and treatment of disease.